Strengthening Research, Training and Outreach Capacity in Huntsman Cancer Institute's Mountain West Service Area

Project Summary/Abstract:
Huntsman Cancer Institute (HCI) at the University of Utah is the only NCI-designated
Comprehensive Cancer Center in the Mountain West (Idaho, Montana, Nevada, Utah, Wyoming). With this
proposal we intend to support and expand the science of cancer health disparities (CHD) research and training
while simultaneously building the next generation of competitive underrepresented cancer and CHD trainees
and investigators in the region. To achieve this we will employ these Specific Aims: 1) Identify new trainees
and early-stage investigators while continuing to support existing pipeline scholars. Continue
recruitment and partnership formation efforts in cancer disparities research by identifying underrepresented
investigators/trainees and providing evidence-based career/professional development activities. 2) Provide
evidence-based career development and networking activities to drive STEM pipeline competitiveness.
Provide and/or connect Mountain West scholars and trainees to career development activities at HCI, U of U
and partners. 3) Track and monitor progress and productivity of newly identified potential pipeline
scholars. We will continue to track and monitor the success of these programs and initiative, and evaluate
their effectiveness. HCI, the Project Director (PD), Programs Coordinator, and Training Navigator will
accomplish these aims by implementing regionally tailored programs and initiatives that will build upon the
training hub momentum.

Public health relevance
Project Narrative: The HCI training hub will contribute to the science of cancer health disparities (CHD) and promote the development of competitive, underrepresented cancer and CHD investigators. HCI and member program partners will increase dialogue, fuel collaborations, spur innovation, enhance diversity training, and positively impact cancer care in underserved communities.